Latino Youths Coping with Discrimination: A Multi-Level Investigation in Micro- and Macro-Time admin supplement

Project Summary
Exposure to discrimination-related stressors (e.g., racial/ethnic discrimination, unfair treatment) continues
to pose a public health challenge to minority populations as a social determinant of health. Although
discrimination-related stressors have been consistently associated with poor mental health outcomes, there is
a critical need to identify mechanisms and malleable risk/protective factors to integrate in the design of
community and clinical interventions. The overall objective of this administrative supplement is to support staff
to facilitate successful completion of data collection in Year 5 as part of the overall R01 application. The project
investigates mediators and moderators at multiple ecological (individual, family/peer and school/neighborhood
levels) and time-scale (micro- and macro-time) levels in the link between discrimination-related stressors and
mental health among Mexican-origin youth. Guided by a socioecological, life course perspective, the proposed
project has three specific aims: (1) determine within-person discrimination-related stressors that impact Mexican-
American origin youth’s mental health outcomes as well as the mechanisms of action at both micro- and macro-
time levels; (2) identify protective factors that could help youth to successfully cope with discrimination-related
stressors and the conditions under which those protective factors work; and (3) elucidate the youth, parent, and
neighborhood risk factors that moderate the link between discrimination-related stressors and mental health in
youth.
The project’s long-term goal is to improve the mental health of Mexican-origin youth by reducing the
deleterious effects of racism, “othering,” and negative neighborhood interactions. The central hypothesis is that
this link will be mediated by cognitive and/or affective mechanisms (i.e. anger, hypervigilance, emotion
regulation, low social position as threats to self-worth) and moderated by coping resources (parental
adaptation and racial socialization) and family, peer, and neighborhood supports, thus representing multiple
ecological levels. Community-based collaboration will help ensure recruitment of the targeted sample of
Mexican-origin adolescents, mothers, and fathers; the inclusion of fathers will be a valuable contribution to the
literature, given the dearth of studies on Latinx fathers/stepfathers. Through the innovative integration of both
yearly longitudinal (macro-time) and daily diary (micro-time) research design features, important questions
about how mediating and moderating processes unfold over time will be addressed. The proposed analyses
also reflect the multi-layered sociocultural niches occupied by Latinx adolescents by employing individual-level
methods as well as dyadic (adolescent-mother; adolescent-father) and triadic (adolescent-mother-father)
analyses to test key study hypotheses. Considering the current growth of Latinx immigrants, it is imperative to
test a socioecological model of risk and resilience for Mexican-origin adolescents that is responsive to both
their immediate context and the larger global forces around migration. This research is highly translational in
that it will facilitate the development of more effective, culturally sensitive prevention and intervention strategies
for Latinx youth and their families.

Public health relevance
Project Narrative Few longitudinal studies have explored why and how discrimination-related stressors for Latinx youth, the largest minority group, convey risk for negative mental health outcomes, and the mechanisms leading to or moderating such risk. This supplement supports staff to carry out R01 aims to evaluate specific malleable risk and protective factors at multiple ecological levels so that findings can aid in the development of targeted, culturally sensitive preventive interventions.